The eXtraordinarY Babies Study: Natural History of Health and Neurodevelopmentin Infants and Young Children with Sex Chromosome Trisomy

PROJECT SUMMARY
Background: Sex Chromosome Trisomies (SCT) including Klinefelter (XXY), XYY syndrome, and Trisomy X
(XXX), occur in 1 out of every 500 births. In childhood there are increased risks for language and learning
disabilities, ADHD, autism, and emotional disorders. Medically, SCTs are associated with testicular failure in XXY,
ovarian failure in XXX, and all have increased morbidity and mortality due to high risks for insulin resistance,
seizures, and other health conditions. Prenatal SCT diagnosis has drastically increased over the past decade in
the US with more widespread noninvasive prenatal screening (NIPS). The eXtraordinarY Babies Study was
launched in 2017, and has enrolled the largest and most diverse prenatally diagnosed SCT cohort to date, including
271 infants followed prospectively from 2 months to 3-4 years of age with detailed medical, hormonal, and
developmental phenotyping coupled with a longitudinal biobank including over 1300 biospecimens. Results have
identified medical features not previously described in SCT, detailed acquisition of developmental milestones, and
identified differences in early speech and behavior profiles known to be `red flags' of later diagnoses such as
autism, dyslexia, and ADHD.
Despite successes described above, we have gaps in our dataset due to COVID research restrictions during a
significant portion of our data collection period, and uncertainty about renewal funding for the continuation of this
project. The focus of this administrative supplement year will be to complete comprehensive data collection for the
36-month in-person visits (including direct neurodevelopmental assessment and biospecimen collection that was
not possible due to COVID). This will allow for achievement of a complete dataset through 36-months of age which
was the primary endpoint for the 1st phase of the study (2017-2022). We aim to: (1) Describe and compare the
natural history of neurodevelopment, medical and hormonal profiles of SCT, and (2) To identify predictors of
phenotypic variability in developmental and health outcomes in SCT. We will maintain the current Biobank.
Approach: Current study participants (n=271) ranging from 12 to 60 months of age will complete an annual
assessment, with goals of completing 50 36-month in-person visits, and the remainder conducted by telehealth.
Demographics, health, family history, and interventions will be collected, along with assessments of: (1) cognitive,
psychological and motor functioning; (2) physical and gonadal measures and (3) quality of life. Statistical models
will contrast longitudinal profiles for each SCT group and compare to population norms. Linear models and logistic
regression will test the association between potential early risk factors and selected outcomes at 36 months. The
biorepository will be expanded and maintained. Impact: The largest cohort of prenatally identified children with
SCT provides a novel resource that will inform the natural history of developmental and medical profiles in SCTs,
guide genetic counseling, identify targets for intervention trials, inform newborn screening, and provide an
invaluable data and biospecimen repository for future research.

Public health relevance
NARRATIVE: Sex Chromosome Trisomies (SCT), including Klinefelter (XXY), Trisomy X (XXX), and XYY syndromes, are the most common chromosomal abnormalities, occurring in 1:400 births and over 10,000 births per year in the US. The prenatal diagnosis rate of SCT has been increasing, and children born with SCT have a significantly increased risk for: (1) neurodevelopmental problems including developmental delays, speech-language disorders, learning disabilities, ADHD, autism, and (2) medical comorbidities including testicular/ovarian failure, disorders of insulin resistance, seizures, congenital malformations, and other medical problems. The eXtraordinarY Babies Study is a prospective natural history study of children with a prenatal diagnosis of SCT, and this supplement year will continue data collection (emphasizing 36-month outcomes) from a group of over 270 infants with SCT who have been comprehensively evaluated with a focus on identifying developmental and hormonal predictors of neurodevelopmental and health outcomes; results will leading to a comprehensive understanding of the natural history and variability in SCT conditions, will identify targets for interventions, and will inform clinical care and genetic counseling guidelines for the increasing number of prenatal diagnoses of SCT.